GABP is a novel regulator of beta cell metabolism and proliferation

PROJECT SUMMARY
Reduced beta cell mass underlies insulin deficiency leading to hyperglycemia in type 1 diabetes (T1D). Restoring
autonomous glucose control in T1D requires beta cell replacement therapy, which is dependent on strategies to
regenerate endogenous beta cells and expand islets ex vivo for transplant. However, there are no current
therapeutic approaches to regenerate beta cells for people with T1D. Thus, our long-term goal is to identify
targets to expand beta cell mass in order to restore glucose control for patients with T1D. To address this, we
established a robust model of beta cell expansion through acute whole-body disruption of the leptin receptor
(LepR). We found LepR deletion induces durable and remarkable beta cell expansion, even in ~2-year-old mice.
Unbiased approaches nominated the transcription factor GA-binding protein (GABP) as a novel regulator of beta
cell metabolism and proliferation. GABP is an ETS transcription factor that forms a heterodimeric complex with
GABPa as the obligate DNA binding subunit. However, the function of GABPa in beta cells is unknown. Our
preliminary data show glucose induces GABPA expression in human islets. Studies in other cell types
demonstrated GABP is required for mitochondrial biogenesis, oxidative phosphorylation, and cell cycle regulation.
These cellular functions are essential to generate ATP and synthesize key molecular building blocks to support
cell proliferation. Nutrient and mitogenic signals also converge on GABP, providing further evidence that GABP
is a rate limiting transcription factor that responds to increases in metabolic demand to stimulate cell proliferation.
Thus, we hypothesize that GABP couples expression of metabolism and cell cycle genes to promote beta cell
proliferation. In this proposal we will pursue the Aim to define the mechanistic role of GABP in human and mouse
beta cell proliferation. To accomplish this, we will leverage beta cell specific Gabpa knockout mice to quantify
the in vivo physiologic and proliferation responses to increased metabolic demand. In human islets studies, we
will deplete GABPa to assay beta cell function, proliferation, and mitochondrial respiration following nutrient
stimulation and pursue mechanistic studies via metabolomics and genome-wide approaches. These
experiments will reveal how GABPa drives beta cell proliferation in response to metabolic demand and will direct
new strategies to expand beta cells for people with T1D.

Public health relevance
NARRATIVE Type 1 diabetes (T1D) is a chronic illness resulting from loss of insulin producing beta cells leading to high blood glucose levels. Restoring autonomous glucose control in T1D requires beta cell replacement therapy, which is dependent on strategies to regenerate endogenous beta cells and expand islets ex vivo for transplant. This proposal will define new signaling mechanisms governing beta cell proliferation that may exert therapeutic benefits for people with T1D.